The Comparative Effectiveness and Safety of Second-line Therapy in Patients with Type 2 Diabetes

PROJECT SUMMARY/ABSTRACT
Jung-Im Shin, MD, PhD, is an Assistant Scientist in the Department of Epidemiology at the Johns Hopkins
Bloomberg School of Public Health. She seeks a K01 Mentored Research Scientist Development Award in
order to obtain essential skills and mentored research experience for an independent career as a research
scientist in the field of pharmacoepidemiology and diabetes. The research proposal details a five-year plan
consisting of in-depth training in novel causal inference methods, mentorship by Dr. Morgan Grams, MD,
PhD, and Dr. Elizabeth Selvin, PhD, MPH, and pharmacoepidemiologic research in utilization, effectiveness,
and safety of second-line therapy in patients with type 2 diabetes. The specific aims of the research agenda
are to: 1) Describe the real-world epidemiology of second-line therapy among people with diabetes after
metformin monotherapy; 2) Evaluate real-world effectiveness of 5 classes of second-line therapy for
hyperglycemia management among similar people with diabetes after metformin monotherapy; and 3)
Evaluate real-world risks of adverse events and benefits on long-term clinical outcomes of 5 classes of second-
line therapy among similar people with diabetes after metformin monotherapy. Immediate career goals include
the mastery of applying target trial emulation and estimating the effect of a dynamic treatment regime with
Robin’s g-methods through an academic curriculum integrated with the research plan. Long-term, Dr. Shin
aims to lead independent research programs investigating optimal treatment and decision-making to improve
health outcomes of patients with type 2 diabetes. Completion of the proposed aims will provide vital information
relevant to the approximately thirty million U.S. patients with type 2 diabetes. Type 2 diabetes is associated
with high levels of morbidity and mortality. Although consensus exists around first-line therapy, there remains
great uncertainty regarding the optimal choice of a second-line therapy, with inconsistent recommendations
across guidelines. A better understanding of the risks and benefits of different classes of second-line
antidiabetic drugs would greatly help clinical practice in patients with type 2 diabetes.

Public health relevance
PROJECT NARRATIVE Although consensus exists around first-line therapy in type 2 diabetes, there remains great uncertainty regarding the optimal choice of a second-line therapy, with inconsistent recommendations across guidelines. The results of this project will provide evidence for knowledge gaps that underlie core clinical practice by a comprehensive assessment of the risks and benefits of second-line antidiabetes drugs.